Improving olfactory neuroplasticity through FAK/CNTF signaling

Project Summary
Olfactory sensory neurons (OSNs) in the olfactory epithelium (OE) are continuously replaced from basal stem
cells and grow their axons to the olfactory bulb to maintain the sense of smell. Failure to reconstitute the OE
after injury, infection or aging, causes olfactory dysfunction which is a safety and a quality of life issue. No
treatments are available. Defining the signals that regulate olfactory neuroplasticity would reveal new
therapeutic targets to improve olfactory deficits. Ciliary neurotrophic factor (CNTF) is highly expressed in
horizontal basal cells (HBCs) and olfactory ensheathing cells (OECs), while the CNTFRα receptor is expressed
in the neighboring neuronal progenitor globose basal cells (GBCs). We found that CNTF is suppressed by
focal adhesion kinase (FAK) and that intranasal application of an FAK inhibitor promotes OE neurogenesis via
CNTF. Importantly, FAK inhibitor further enhances CNTF expression caused by OE injury with methimazole.
We will use genetic, pharmacological, and behavioral approaches in male and female mice to test the
hypothesis that FAK inhibition promotes olfactory neuroplasticity following injury by increasing CNTF
expression. Aim 1 will define the FAK-CNTF-CNTFRα pathway underlying GBC proliferation by first
determining whether FAK inhibition induces CNTF in HBCs, OECs or both. We will also determine whether
CNTF is released to activate CNTFRα signaling in stimulating GBC proliferation, and whether FAK inhibition
acts through this intercellular mechanism. To increase the relevance of our findings, Aim 2 will determine
whether FAK inhibition can increase olfactory neurogenesis via CNTF following acute OE injury. Thus, we will
use acute injury with methimazole and determine whether injury increases CNTF in HBCs and/or OECs which
leads to increased GBC proliferation and neurogenesis. The effect of FAK inhibitor treatment following
methimazole may be within HBCs and/or OECs, something we will test. To prepare for additional studies, we
will define an optimal dose of FAK inhibitor and then test whether CNTF mediates the effect of FAK inhibitor to
promote OE neurogenesis after acute injury. Chronic olfactory inflammation inhibits HBC proliferation and
increases FAK signaling in HBCs, suggesting that CNTF might be suppressed. To broaden the relevance to
more types of olfactory injuries, Aim 3 will use a refined chronic olfactory inflammation mouse model to
determine whether FAK inhibition increases CNTF and promotes GBC proliferation and olfactory
neurogenesis. Aim 4 will determine the ability of FAK inhibition to promote OSN axonal growth and olfactory
function recovery following acute and chronic types of OE injury, using genetic axon tracing methods combined
with behavioral tests. This proposal will define the role of FAK and CNTF and validate the therapeutic potential
of FAK inhibitors to improve olfactory function after injury. FAK inhibitors are well-tolerated in cancer clinical
trials and intranasal administration avoids systemic side effects.

Public health relevance
Project Narrative This grant examines the roles of ciliary neurotrophic factor (CNTF) and focal adhesion kinase (FAK) inhibition on olfactory neuroplasticity and function. We will use behavioral, genetic and pharmacological approaches to define the roles of CNTF and FAK inhibition-induced CNTF expression in regulating olfactory neuroplasticity and function following acute and chronic olfactory epithelium injury. We expect to identify a novel target, FAK, for injury-related loss of the sense of smell.